Augmented Preclinical Alzheimer's Disease Detection Through Wearable Health and Driving Behavior Data.

PROJECT SUMMARY
By 2050, 88 million (20%) Americans will be ≥ age 65, representing a doubling of the population along
with 25% of all drivers being an older adult. Given that there exists a long preclinical stage of Alzheimer's disease
(AD) lasting around 20 years, there is a need to develop low-cost modifiable behavioral interventions. The
proposed study expands on the substantial work by two teams: 1) Amissa Health’s NIH SBIR-funded research
platform that allows for remote patient monitoring through commodity smartwatches (e.g., an Apple Watch) and
2) The NIH/NIA-funded DRIVES Project from Washington University School of Medicine in St. Louis that uses
in-vehicle driving loggers to capture driving behaviors in individuals with and without preclinical AD. This study
aims to investigate the relationship between health-related data collected from the Amissa Platform and Apple
Watch among older adults coupled with driving behavior data to classify preclinical AD status.
Aim 1 focuses on assessing the relationship between health-related data collected from the Amissa
Platform and Apple Watch and cognitive function in older adults with and without preclinical AD. A cohort of
cognitively normal older adults (≥ age 65, n=50) will be recruited from an existing DRIVES Project. The participant
preclinical AD status will have been determined using amyloid tracers via Positron Emission Tomography (PET).
In addition, neuropsychological assessments will be administered to participants to comprehensively evaluate
cognitive functions such as memory, attention, executive functions, and visuospatial abilities. Health-related
parameters, such as heart rate, oxygen saturation, sleep patterns, and physical activity, will be continuously
recorded using the Apple Watch and AmissaWear. The data will be analyzed to identify relationships in health-
related parameters and cognition by preclinical AD status.
The goal of Aim 2 is to determine whether health-related data from the Amissa Platform and Apple Watch,
combined with real-world driving behavior data, collected from in-vehicle loggers, can predict preclinical AD
status. Participants from Aim 1 will be equipped with DRIVES chips to continuously capture driving performance
metrics, including speed, acceleration, braking, and lane deviations. The second Aim will integrate the collected
wearable health sensor data with driving data with the goal of developing a robust machine learning model to
predict preclinical AD status. This model aims to augment the existing neuropsychological assessment
techniques with lower-biased health sensor and driving behavior data and to better estimate cognitive decline
and driving risks among older drivers.
This innovative research project introduces novel approaches, including the use of popular smartwatches
for data collection, a centralized biometric database for AD research, and the integration of health and driving
data. It aims to provide accessible and stigma-free data collection methods for participants while enhancing our
understanding of preclinical AD.

Public health relevance
PROJECT NARRATIVE This collaborative research between Washington University School of Medicine in St. Louis and Amissa Health aims to assess the relationship between health-related data collected from wearable devices and driving behaviors among older adults with and without preclinical Alzheimer’s disease (AD). This Phase I SBIR aims to advance the data and knowledge of the relationships between preclinical AD and biometric/behavioral measures. The proposed research is clinically relevant as it could provide early predictive insights into AD. The goal is to identify and validate digital biomarkers relevant in the classification of AD years before the onset of symptoms while augmenting the use of neuropsychological assessments.